BEVERAGE TYPE ON ETHANOL INDUCED FATTY ACID ETHYL ESTER PRODUCTION

This study is designed to determine whether the production of fatty acid ethyl esters (FAEE), metabolites of ethanol found in blood; (1) varies between men and women, and (2) is influenced by the type of alcohol beverage consumed.